Addressing Sexual and Reproductive Health Care Disparities and Barriers among Adolescents and Young Adults with Disabilities

PROJECT SUMMARY
Studies to date suggest that the sexual and reproductive health (SRH) care needs of adolescents and young
adults (AYA) with disabilities are not well met, despite the fact that this population is as likely to be sexually
active as their peers without disabilities. However, research on SRH and receipt of SRH-related health care
among AYA with disabilities remains limited. Scant evidence informs our understanding of the reproductive
healthcare needs of both young women and men with disabilities by disability type and there is no research on
reproductive healthcare service utilization across the breadth of this diverse population. Further, there are few
resources to help AYA with disabilities navigate barriers to SRH care and obtain needed services. This mixed-
methods study will examine SRH and healthcare utilization and SRH-related unmet needs among transition
age adolescents and young adults with disabilities overall and by disability type in the United States. We will
triangulate information from national survey data, interviews with AYA with disabilities, and interviews with
parents of AYA with disabilities. Our analyses will address three fundamental questions that will establish a
foundation for development and pilot testing of a tailored intervention to improve SRH care and outcomes for
AYA with disabilities, ages 15-26: 1) What disparities exist in reproductive health care service utilization by
gender and type of disability; 2) What are the barriers to SRH care for AYA with disabilities and how are these
similar or different by gender and disability type?; and 3) What SRH information and resources would enhance
knowledge, participation in care, and communication with providers for AYA with disabilities? Building on this
foundation, we will collaborate with AYA with disabilities to develop an intervention to address the identified
barriers and unmet needs. Our project directly addresses unmet needs for SRH care identified by the National
Institutes of Health, including (1) investigating barriers to reproductive health care for AYA with disabilities, and
(2) developing reproductive health education materials for use by AYA with disabilities. This project builds on
the research team’s prior research on reproductive health of teens and women with disabilities, experience in
developing health education curricula and sexual health resources for people with developmental disabilities,
and clinical expertise in provision of care to people with disabilities transitioning from adolescence to
adulthood. The expected outcome of this project is an innovative, accessible, multi-media educational toolkit to
improve SRH knowledge and activation and provider communication. Our pilot testing will provide initial
evidence on the utility of the toolkit for our target population, establishing a foundation for future efficacy testing
in a clinical trial. This project will break new ground by providing a foundation of evidence on SRH health and
healthcare outcomes, and will develop an innovative SRH educational toolkit to address barriers and
disparities among AYA with disabilities.

Public health relevance
PROJECT NARRATIVE Studies to date suggest that the sexual and reproductive health (SRH) care needs of adolescents and young adults with disabilities are not well met. The proposed study will generate national, population-based estimates of sexual and reproductive health risks and outcomes among transition-age adolescents and young adults with disabilities, and also examine their unmet needs and barriers to SRH care. The study will produce an evidence-based, accessible sexual and reproductive health education toolkit for adolescents and young adults with disabilities to improve their SRH and healthcare experiences and promote active engagement in their own care.